Advances in Sleep and Circadian Science

Abstract
The Sleep Research Society (SRS) is dedicated to promoting and advancing the scientific
understanding of sleep and circadian rhythms across the translational spectrum, from their
molecular regulation across species, to their cross-generational transmission through genetic,
epigenetic, cultural, and social forces, to their impact on health and functioning. Inexorably linked,
sleep and circadian rhythms entrain and sustain physiological and behavioral processes critical
to survival, such as immune, psychiatric/neurologic, metabolic, and motor functions. In 2017,
circadian biologists Michael Young, Michael Rosbash, and Jeffrey Hall were awarded the Nobel
Prize in Physiology or Medicine for their discoveries that propelled our understanding of the
molecular mechanisms controlling circadian rhythms. Advances in the molecular underpinnings
of circadian rhythms have, in turn, informed our understanding of the cellular and molecular
mechanisms of sleep. Yet, despite the physiological and behavioral links between sleep and
circadian rhythms, the fields of sleep and circadian science have evolved somewhat
independently, limiting their reach and scope. The SRS seeks to redress this issue by organizing
a unique transdisciplinary sleep and circadian science conference to promote interdisciplinary
cross-talk, extensive discussion of cutting-edge science, identification of gaps in knowledge and
opportunities to catalyze transdisciplinary research, and specialized programming for trainees
and early stage investigators, who represent the future of this important transdisciplinary field.

Public health relevance
Project Narrative The Advances in Sleep and Circadian Science meeting is scheduled for February 17 – 20, 2023 in Clearwater, Florida. This small, single-track meeting will include cutting-edge research that bridges, or has great potential to bridge, sleep and circadian science. Each session will highlight the research of high-impact sleep and circadian scientists and conclude with discussion, moderated by an eminent sleep and/or circadian scientist, who will be charged with eliciting from the group critical gaps in knowledge, opportunities, and important next steps that could catalyze truly transdisciplinary sleep and circadian science. Sessions are focused on the control and outputs of sleep and circadian rhythms across the lifespan and translational spectrum including microbiome/metabolism, physical performance, neuropsychiatric disruption, sensory processing, immune function, and autonomic function. A separate session on considering sex as a variable is also planned, as is a session on reconsidering the way in which we quantitate sleep and circadian rhythms. Eminent and emerging sleep and circadian scientists have been invited to participate in this transformative meeting. Already confirmed are Ken Wright, David Gozal, Karyn Esser, Juleen Zierath, Neil P Walsh, Dara Manoach, Shinjae Chung, Giorgio Gilestro, Jessica Mong, Monika Haack, Jeff Haspel, John Axelsson, Meredith Wallace, Philippe Mourrain, Roberto Amici, Emmanuel Mignot, Satchin Panda, Phyllis Zee, Paul Shaw, Ying-Hui Fu, Amita Sehgal, Derk-Jan Dijk, Lara Dugas, Jason Rihel, Anita Lüthi, Ken Paller, Katie Stone, Janet Mullington, Rosemary Braun, Daniela Grimaldi, and Frank Scheer.